Administrative Core

ADMINISTRATIVE CORE
PROJECT SUMMARY/ABSTRACT
The Administrative Core (AC) over the previous cycles has been effective in establishing the foundation of the
Partnership and providing critical support across all components of the project: research, outreach, education,
infrastructure, and professional development. In this renewal, the AC will continue to serve as a facilitative
resource to provide strategic leadership and oversight in the development, implementation, coordination, and
management of all Partnership activities for the Partnership's Infection-Driven Malignancies Program for
Advancing Careers and Translational Sciences (IMPACT). This core, which works collaboratively with the
Planning and Evaluation, and DATAOmics Cores, provides assistance with the daily activities of the
Partnership, including, but not limited to, grants management, program management, and meeting planning,
as well as to spearhead short-term and long-term strategic planning and prioritization for the successful
achievement of Partnership initiatives. At each institution, the AC is composed of three principal investigators,
and one program director. Specific Aims for the AC include: 1) Provide leadership, administrative
management, and organizational infrastructure, including leading overall strategic planning and oversight
of program implementation, assessment and evaluation; 2) Oversee the scientific research agenda to ensure
program goals are clearly defined and aligned with the goals of the grant, and that activities are thoughtful,
well-planned, and scientifically sound; 3) Ensure core operations are efficient and integrated, project
deliverables are met, regular communications among the cores and projects are in place and facilitated, and
program goals for progress monitoring, outcomes documentation and deliverables are met; 4) Engage,
develop, and maximize collaborations with other U54 Partnerships, as well as other internal and external
entities to promote sustainability; 5) Support communications across the Partnership's projects and cores and
with the Internal Advisory Committee (IAC), Program Steering Committee (PSC) and NCI CPACHE program
office; 6) Augment the cancer research capacity of the UPR and the UPRCCC through the development of
targeted hires and leveraged strategic collaborations; and 7) Establish a centralized Scientific
Communication Core (SciCom) to provide a wide range of educational, editorial, and publishing services, free
of charge, to UPR and UPRCCC faculty and students. This core will strengthen the overall cancer research
enterprise in infection driven malignancies in PR and TX, and will support the implementation of UPRCCC's
roadmap leading to the submission of a CCSG (P30) for NCI designation as a Cancer Center.